How Do Lower Limb Prosthetic Stiffness and Power Affect the Biomechanics, Metabolic Costs, and Satisfaction of Veterans with Transtibial Amputations DuringWalking?

Previous studies suggest that use of the recommended prosthetic foot stiffness category and/or ankle
power output setting may not optimize the function of Veterans with transtibial amputations (TTAs). Due to the
functional impairments and lifetime of healthcare costs incurred by Veterans with TTAs, it is vital to determine
how different prosthetic foot and ankle properties/parameters such as passive-elastic prosthetic foot stiffness
and battery-powered prosthetic ankle power output affect the metabolic cost and biomechanics of Veterans
with TTAs. Further, determining the optimal prosthetic foot stiffness and/or power output could dramatically
improve the function of people with TTAs, which would promote increased physical activity, while reducing pain
and the risk of comorbidities. Veterans with TTAs typically use a passive-elastic prosthetic foot such as the
Össur Low Profile Vari-flex with Evo (LP) with a stiffness category based on manufacturer-recommendations,
user body mass, and anticipated activity level. Previous evidence demonstrates that Veterans with TTAs using
the recommended passive-elastic prosthetic foot stiffness category for walking have greater metabolic
demands, asymmetric biomechanics, leg and back pain, and discomfort compared to non-amputees. Further,
some Veterans use a battery-powered ankle-foot prosthesis such as the Ottobock BiOM. [The Össur Low
Profile Vari-flex with Evo (LP) is the only passive-elastic prosthetic foot that integrates with the BiOM. The LP is
utilized beneath (in-series with) the BiOM with a stiffness category based on manufacturer-recommendations,
user body mass and activity level. Then, the BiOM is tuned by adjusting nine different parameters within the
prosthesis using different software settings so that the combination of the user and prosthesis produce net
positive prosthetic ankle work equivalent to average non-amputee net positive ankle work within two standard
deviations (SD) of the mean. Use of BiOM has resulted in normative metabolic costs and biomechanics for
people with TTAs compared to non-amputees, but one study found that use of the BiOM with a recommended
LP prosthetic foot stiffness category and prosthetic power output setting did not elicit differences in metabolic
cost at preferred walking speeds compared to use of participants’ own passive-elastic prosthesis.]
We will systematically assess how prosthetic foot stiffness and power output affect physical function in
Veterans with TTAs. First, we will quantify prosthetic and torsional stiffness (force/displacement or
torque/angle) values of LP prostheses. Determining stiffness values (in kN/m and kN·m/rad) for a given
passive-elastic prosthetic foot stiffness category is essential for deriving the dynamic biomechanical function of
prosthetic feet. Then, we will systematically measure and compare the metabolic cost, biomechanics, muscle
activity, and satisfaction resulting from using the LP passive-elastic prosthetic foot alone with four stiffness
categories, and the BiOM battery-powered ankle-foot prosthesis combined with four LP prosthetic foot stiffness
categories and three different magnitudes of prosthetic ankle power output during walking over a range of
speeds. Our results will provide a mechanistic understanding of prosthetic stiffness and power to inform
prosthetic design and control, which will improve and expedite rehabilitation of Veterans with TTAs and the
quality of services provided by the VA, while saving time, money, and resources. By improving prosthetic
design and control, our results could ultimately allow Veterans with TTAs to regain the greatest possible level
of physical function, improve their health, maximize their recovery and rehabilitation, facilitate their return to
work/duty, and potentially improve their quality of life. Long-term goals for prosthetic design should include
“smarter” prostheses that can change stiffness dynamically, generate net positive mechanical work, and
dissipate mechanical work. However, a critical barrier to developing such advanced prostheses is our lack of a
fundamental understanding of the effects of different prosthetic foot stiffness and power output on the
metabolic costs, biomechanics, and satisfaction of Veterans with TTAs during level-ground walking.

Public health relevance
Previous studies suggest that Veterans with a below the knee amputation using passive-elastic or powered prostheses have impaired physical function, which could increase the risk of osteoarthritis, leg/back pain, and diabetes/obesity. Use of an advanced prosthesis that has optimal stiffness and power output could thus restore function, which would increase physical activity and reduce risk. We will systematically determine the independent and combined effects of using a passive-elastic prosthesis with different stiffness categories beneath a battery-powered ankle-foot prosthesis with different magnitudes of prosthetic power output on the metabolic cost (effort), biomechanics (movements and forces), muscle activity, and satisfaction for Veterans with below the knee amputations during walking at a range of speeds. Such evidence-based measures would enhance prosthetic technology, which could reduce comorbidities, while improving quality of life, comfort, and physical function, and advancing rehabilitation research and development for Veterans with leg amputations.